The International Mammalian Genome Conference

The International Mammalian Genome Society (IMGS) was established in 1990 to foster and stimulate
mammalian genetics research in areas ranging from genome annotation, sequence comparison and
functional genomics to mutagenesis and quantitative trait analysis, and to represent the concerns of its
members in their professional activities. For over 33 years, the IMGS has sponsored the annual
International Mammalian Genome Conference (IMGC), which provides a forum for scientific and policy
discussions, and a venue for scientists in training to network with leaders in mammalian genetics and to
present their work at an international venue. The objective is to provide scholarships for the annual IMGC
for students and postdoctoral fellows, particularly targeting URGs. Previous conferences have been
highly successful at providing a forum for the mammalian and biomedical genetic community and a venue
for student and postdoctoral scholars to present their research and interact with leaders in the
mammalian genetics community. Substantial enhancements have been implemented for these
conferences with the goal of improving the benefit of the IMGC to the broader mammalian genetics
community and increasing participation by scientists-in-training. The improvements include sessions on
large-scale resources and infrastructure, phenotyping for pre-clinical models, rigor and reproducibility,
mentorship sessions, and participation by scientists-in-training on the IMGS Secretariat. With recent
discoveries in human genetic analysis now being translated to functional studies in relevant model
systems, the importance of a meeting with a focus on the optimal utilization of these resources is clear.

Public health relevance
The International Mammalian Genome Conferences provide an essential annual venue that brings together mammalian and biomedical geneticists from across the world to interact, form new collaborations and plan new research programs with the goal of improving the use of mammalian models to improve the health and well-being of people. An important aspect of the conferences is the training and mentoring of young scientists. The first site of this proposal is in Washington, DC by joining with the Genetics Society of America at the pan-organismal Allied Genetics Conference (TAGC) that is held every 4 years for the third time.